MISOPROSTOL FOR MEDICAL MANAGEMENT OF ABNORMAL FIRST TRIMESTER PREGNANCY

Participants in this research study will include healthy women over the age of 18 who have an early pregnancy that is not normal and cannot become a normal pregnancy. Doctors usually suggest that the abnormal pregnancy be removed from the uterus (womb). This is usually done by a surgical procedure called a dilation and curettage (D&C). With a D&C, a small suction instrument would be put up into the uterus to take out the abnormal pregnancy. The purpose of this study is to test the safety and effectiveness of a medicine called misoprostol to remove this abnormal pregnancy tissue from the uterus without needing this surgical procedure. NCRR Clarification: research is on abnormal pregnancy/miscarriage